Elucidating the molecular mechanism and physiological relevance of TIRR mediated inhibition of p53

53BP1 influences genome stability via two independent mechanisms: (i) a direct role in DNA double-strand break
(DSB) repair, (ii) enhancing the activity of p53 as a transcription factor. The role of 53BP1 in DSB repair has
been well described with a large body of literature. However, there is very limited understanding of how 53BP1
impacts p53 with contrasting reports on mechanism and function. Perturbing ‘normal’ mitosis caused a p53-
dependent cell cycle arrest which was dependent on 53BP1 and its known interactor USP28. The suggested
mechanism was that 53BP1/USP28 played a role in the stability and nuclear localization of p53. Another study
reported that 53BP1/USP28 accentuated the transactivation function of p53 in response to DNA damage/stress.
Loss of 53BP1/USP28 impaired the chromatin recruitment of p53 but did not impact p53 protein levels. We
recently identified TIRR (Tudor Interacting Repair Regulator), as a direct interactor and regulator of 53BP1
function in DSB repair. 53BP1 recruitment to DSBs by recognition of histone H4 dimethylated at lysine K20 is
inhibited by TIRR binding to the Tudor domain of 53BP1. Like p53, TIRR also binds 53BP1 independent of
chromatin and DSBs. We speculated that TIRR may regulate the interaction of p53 with 53BP1, and influence
53BP1-mediated activation of p53. Loss of TIRR indeed enhanced the interaction of 53BP1 and p53 resulting in
an aberrant increase in p53’s gene-transactivation function. TIRR specifically inhibited the complex formation
between the Tudor domain of 53BP1 and a dimethylated form of p53 that is poised for transcriptional activation
of its target genes. The impact of TIRR loss on p53 gene expression was partially rescued by depletion of 53BP1
or USP28. Therefore in Aim 1 we propose to investigate the interplay of TIRR with 53BP1/USP28 in regulating
p53 transactivation function. TIRR is a RNA binding protein and our prior structural studies revealed two non-
canonical RNA binding motifs in TIRR. We systematically identified TIRR bound transcripts and discovered that
TIRR directly binds transcripts of several p53-regulated genes. The binding occurs near the transcription start
sites (TSS) and the 3’UTR of these transcripts. Based on this data we hypothesize that TIRR may influence
transcriptional elongation and mRNA stability, providing a 53BP1-independent mechanism by which TIRR
regulates the p53 signaling axis. This hypothesis will be tested in Aim 2. Exploring the clinical relevance of TIRR
mediated inhibition of p53, we observed that amplification of the TIRR genomic locus in human carcinomas is
mutually exclusive from TP53 mutation/deletions and amplifications of the MDM2/4 loci suggesting that these
are distinct mechanisms of suppressing p53 function. We generated a TIRR-deficient mouse model to investigate
the idea that loss of TIRR will prevent the formation of p53-proficient tumors. Our preliminary results support this
idea as these animals in the context of p53 heterozygosity, resembling Li Fraumeni syndrome (LFS) patients,
have dramatically reduced tumorigenesis. In Aim 3 we will define the relevance of TIRR in cancer biology at the
organismal level.

Public health relevance
Project Narrative Loss pf p53 function is a pivotal step in cancer etiology and oncogenessis. The recently identified RNA-binding protein, Tudor Domain-interacting Regulator of DNA Repair (TIRR) inhibits function in a multi-faceted manner (i) via regulation 53BP1/USP28/p53 complex and (ii) direct binding of transcripts from p53 target genes. Our proposal utilizes a combination of genomic, proteomic and genetic tools to understand how TIRR inhibits p53 to promote tumor development.